Novel Strategies for Reprogramming iPS Derived Cardiac Cells

DESCRIPTION (provided by applicant): Reprogramming of adult human fibroblasts into induced pluripotent stem (iPS) cells has generated significant excitement in the fields of regenerative medicine and stem cell biology. iPS cells avoid the ethical issues surrounding human embryonic stem cells (hESCs), and also have the potential for being patient- and disease-specific. However, the current method of integrating transcription factor genes into the adult cell genome requires weeks of cell culture, and so far has resulted in very low yields of iPS cells that may also become oncogenic in vivo. Inefficient delivery of transcription factors to the cells is an obstacle, but more fundamental is the failure of the introduced transcription factors to alter the pre-existing messenger RNA (mRNA) pool already within the adult cell. Thus, the adult cell's existing transcriptome continues to be translated into adult proteins while the transcription factor mRNAs slowly reaches target critical mass before overtaking the adult proteome, thus resulting in delayed pluripotency. To address these problems, we propose an innovative method for reprogramming that is based on microRNAs (miRNAs). MiRNAs are a class of small, noncoding RNA that play important posttranscriptional regulatory roles by targeting mRNA for cleavage or translational repression. The primary advantage of miRNA is that, unlike transcription factors, they will directly and immediately alter the adult transcriptome and proteome, leading to increased efficiency and decreased time for inducing pluripotency. We propose to do this by first determining the miRNA signature of adult cells after introduction of three known reprogramming factors, Oct 3/4, Sox2, and Klf4. Over-expression of this miRNA signature in adult cells using a novel non-viral delivery method should induce pluripotency.

Public health relevance
Project Narrative Ischemic heart disease is the number one cause of morbidity and mortality in the United States. In the past decade, animal studies have shown that transplantation of bone marrow stem cells (BMSCs), endothelial progenitor cells (EPCs), and skeletal myoblasts (SKMs) into the infarcted myocardium can improve cardiac function. These exciting data led to the initiation and completion of phase 1-2 clinical trials involving stem cell transplantation in cardiac patients. However, results from more recent large randomized clinical trials on SKMs, EPCs, and BMSCs are inconclusive, raising further questions as to their true efficacy. One of the main concerns is the possibility that the aforementioned cell types may not transdifferentiate into cardiomyocytes and thus failing to adopt the necessary cellular phenotypes necessary for long-term engraftment in the heart. By contrast, human embryonic stem cell derived cardiomyocytes (hESC-CMs) possess these characteristics. However, immunological intolerance and bioethical concerns still stand as major obstacles for their clinical translation in the future. Here we propose a novel strategy to bypass these two issues by using induced pluripotent stem cell derived cardiomyocytes (iPSC-CMs). iPS cells are genetically modified by the integration of three to four DNA transcription factors into the adult cell genome. Although iPS cells represent a significant advance in stem cell research, many difficulties remain to be resolved to realize their full potential. Two major questions concern their safety and efficacy. To those ends, this multi-disciplinary project will investigate the following aspects: (1) to improve the yield of iPS cells using human mesenchymal stem cells (MSCs) instead of fibroblasts; (2) to use safe non-viral and non-immunogenic minicircle plasmid as vectors; (3) to develop novel reprogramming strategies using microRNAs; (4) to characterize the functionality of iPSC-CMs compared to hESCs; (5) to define the network of genes involved in maintaining pluripotency and regulating differentiation using a systems biology approach; and (6) to apply state-of-the-art molecular imaging technology to track the fate and function of transplanted cells. The knowledge gained from our studies will help facilitate the development of "patient- tailored" cardiovascular regenerative therapies in the future.